STROKE PREVENTION TRIAL IN SICKLE CELL ANEMIA

Multicenter study designed to test the hypothesis that first time stroke in children with Sickle Cell Disease can be reduced by at least 70% using chronic transfusion in children found to be of highest risk by transcranial doppler.